Optimization and Characterization of Novel Antifungal Peptides

PROJECT SUMMARY / ABSTRACT
Invasive candidiasis is a disease associated with significant morbidity and mortality, with only 3 classes of
antifungals available for treatment. While Candida albicans remains the most common species associated with
this disease, other non-albicans Candida species are emerging or growing in prevalence. The global
emergence of Candida auris, a species with a high rate of multi-drug resistance capable of nosocomial
transmission, and reports of Candida glabrata infections resistant to both azoles and echinocandins, highlight
the critical need for new classes of antifungal drugs that can combat resistance and treat invasive fungal
diseases. AimMax Therapeutics is developing a novel class of promising antifungal peptides that are
differentiated from other antimicrobial peptides in development. Peptides have been considered as promising
therapeutics because of their novel mechanisms of action, rapid cidality, low propensity for resistance
development and low potential for drug-drug interactions. However, there are certain liabilities associated with
historical antimicrobial peptides as systemic therapeutics, including propensity for lysis of human cell
membranes causing toxicity and degradation by circulating proteases and peptidases. Our preliminary studies
have shown that: 1) several of the AimMax peptides have antifungal activity across Candida species, including
activity against resistant strains, 2) this activity is rapidly fungicidal in nature, 3) there is no cell lysis or
intracellular cytotoxicity against human cells and they are well-tolerated following repeat dosing in vivo, 4) they
are salt tolerant and retain activity under physiological conditions, and 5) they can be modified to increase
stability against proteolytic degradation and demonstrate good plasma exposure in vivo. The objective of this
proposal is to optimize the peptides by enhancing antifungal activity and microbiological profile, while
maintaining safety (no toxicity) and minimizing proteolytic instability and undesirable physicochemical
properties. These studies are essential to select potent antifungal peptides to combat resistance and ensure
that they are “druggable” for further development. The objectives of the proposal will be achieved by rational
peptide design and structure-activity relationship analysis using data from a series of in vitro and in vivo
screening assessments. Peptides selected based on pre-determined criteria will undergo expanded
evaluations. Together, these studies will form the basis of candidate selection for further development and
IND-enabling work in a Phase 2 SBIR application. The ultimate goal of this program is to develop a broad-
spectrum antifungal drug that will address the rising threat of drug resistance in Candida species and provide
an alternative treatment option for life-threatening invasive candidiasis.

Public health relevance
PROJECT NARRATIVE Invasive candidiasis is a significant cause of morbidity and mortality. The emergence of multidrug resistant Candida species highlights the need for new antifungals. AimMax Therapeutics is developing a novel class of antifungal agents for the treatment of serious and life-threatening invasive fungal infections.